Uncovering the functional diversification mechanisms of transcription factor isoforms involved in stem cell differentiation

Abstract
Ectopic expression of transcription factors (TFs) can drive differentiation of embryonic stem cells, trans-
differentiation between different somatic cell lineages, and reprogramming of somatic cells into induced
pluripotent stem cells. This observation underscores the central role transcriptional factors (TFs) play in gene
regulatory networks to dictate cellular phenotypes. The endogenous activities of TFs can be dramatically
altered through mechanisms such as alternative splicing of TF messenger RNAs, in which multiple, functionally
distinct protein isoforms can be produced from the same gene. Distinct TF isoforms can exhibit differential
abilities to bind DNA targets, cofactors, or chromatin-associated proteins, resulting in complementary or
opposing functions. For example, FOXP1 produces two isoforms that differ in their DNA-binding specificities:
one activates self-renewal pathways, while the other activates differentiation pathways. On a global scale, such
isoform-driven functional rewiring is emerging as a major regulatory strategy that controls differentiation and
development. However, reliably detecting and discovering biologically relevant TF isoforms is challenging,
particularly at the proteome-scale.
To characterize TF isoforms that play a role in stem cell differentiation, my lab will apply a powerful combination
of analytical and systems biology approaches to identify and experimentally characterize the functional
consequences of TF isoforms. This project will involve several interlinked areas, including goals to: 1) discover
and quantify full-length TF isoforms associated with differentiated cell states, 2) find TF isoform “drivers” of
differentiation, and 3) uncover the mechanism(s) by which TF isoforms exhibit different functions. Our approach
will use proteogenomic analysis that integrates long-read sequencing and MS-based proteomics data, high-
throughput functional screening of large-scale isoform libraries, and characterization of molecular determinants
(e.g., protein binding, DNA binding) and activities (gene activation or repression) that underlie differential TF
isoform function. Collectively, the resulting data will enable discoveries of new general mechanisms of cellular
differentiation and their drivers.
This research program will provide a fundamental understanding of how TF isoforms function in regulatory
networks and will contribute to the field by expanding the toolkit of TFs used in stem cell engineering applications.
More broadly, this framework offers a new paradigm to enable isoform-resolved biological investigations, which
could accelerate discovery of key isoform regulators in physiological and pathological states.

Public health relevance
PROJECT NARRATIVE A fundamental understanding of how transcription factors control early development events in human is a critical question in basic biology research. This project uses a new large-scale, systematic approach to study the function of these factors. This work is critical to understand basic mechanisms of development and disease as well as provide knowledge that can be directly applied to develop new applications in regenerative medicine.